VEL-03: IND-enabling development of a novel therapeutic approach for treatment of non-small cell lung cancer and other solid tumors

Project Summary/Abstract
Lung cancer is the leading cause of cancer-related death in the U.S. and worldwide. Non-small cell lung cancer
(NSCLC) makes up 85% of all lung cancers. Despite advancements in targeted cancer therapies, NSCLC has a
5-year survival rate of less than 30%. Current treatment challenges include limited responses to radiotherapies
and targeted therapies, immune resistance in "immune cold" tumors, and complex tumor microenvironment
alterations. In response to the pressing need for effective lung cancer treatments, Velorum Therapeutics has
developed VEL-03, a first-in-class pan-cancer metabolic targeting therapy. Preliminary data demonstrate
disruption of tumor metabolism by targeting heme uptake, a critical factor in cancer growth and progression.
VEL-03, a proprietary heme-sequestering protein, demonstrates consistent efficacy by inhibiting tumor growth
in various cancer models, while sparing normal cells. Moreover, VEL-03 reshapes the tumor microenvironment,
enhancing its synergy with radiation therapy. Collectively, our results identify VEL-03 as a promising therapy for
many hard-to-treat cancers, both as a monotherapy and as a potential combination treatment. This Direct to
Phase II proposal will: 1) evaluate VEL-03’s therapeutic efficacy in combination with radiation therapy and
Cisplatin, 2) scale up manufacturing for IND-enabling studies, and 3) conduct maximum tolerated dose and dose-
finding toxicology studies with pharmacokinetic and pharmacodynamic endpoints. Successful completion of
these Aims will lay the foundation for IND-enablement and subsequent clinical studies of VEL-03 as a single-
agent and in combination with existing anti-tumor agents. Our overall goal is to advance VEL-03 towards clinical
studies with rapid proof-of-concept, addressing a significant unmet need first in lung cancer treatment and
potentially benefiting patients with many types of hard-to-treat cancers.

Public health relevance
Narrative Velorum Therapeutics Inc. is developing first-in-class cancer therapies by leveraging a pan-cancer metabolic vulnerability to inhibit tumor growth and reprogram the tumor microenvironment (TME) across tumor types. This proposal advances the development of VEL-03, a promising therapy that targets heme metabolism, critical metabolic process for cancer proliferation, to treat NSCLC and other solid tumors. VEL-03 has broad utility as both a monotherapy and as a combination therapy that synergizes with immunotherapy, radiation therapy, and other standard-of-care treatment modalities to improve outcomes for patients with diverse types of drug-resistant cancers.